Efficacy of sipIT Intervention for Increasing Urine Output in Patients with Urolithiasis

Project Summary
Kidney stones affect an estimated 8.8% of American adults and direct medical costs exceed $10 billion
annually. Five-year recurrence rates for stones have been as high as 40% and a standard guideline for
prevention is to increase fluid intake enough to produce > 2.5 L of urine daily. Meeting these guidelines
reduces stone recurrence rates by 50-60% yet patients’ adherence to fluid intake guidelines is commonly
below 50%. Usual care for preventing a recurrence involves education about increasing fluid intake and dietary
changes; however, the low adherence rate indicates that many patients would benefit from additional support
in adhering to fluid intake guidelines. The long-term goal of this research is to reduce the recurrence of painful
and costly stones by improving patient adherence to fluid intake guidelines (secondary prevention). Digital
technology offers the promise of increasing reach and supporting treatment adherence but, to date, that
promise has not been fully realized in clinical trials of digital tools for supporting treatment adherence. In a
series of six preliminary studies, we engaged patients in developing and testing a context-sensitive digital tool
called sipIT, a just-in-time adaptive intervention to promote fluid intake and increase urine output. We learned
that patients are open to using digital tools provided those tools are integrated with their lifestyle and sensitive
to the changing contexts of their lives. The resulting intervention, sipIT, incorporates a novel semi-automated
tracking system to trigger smartphone notifications with context-sensitive reminders to drink. The reminder
system was informed by contemporary theories of habit formation to support behavior change in the eventual
absence of the technology. In this application, we propose to answer question, “Does sipIT increase 24-hour
urine output more than usual care over a 3-month period?” Urine output was selected as a proximal surrogate
endpoint based on clinical guidelines for preventing recurrence of kidney stones. The specific aims of this
project are (1) to evaluate the efficacy of sipIT vs usual care for increasing urine output in patients with a history
of kidney stones, and (2) to identify biological and behavioral moderators of intervention effects on urine output
(heterogeneity of treatment effects). We propose a two-arm randomized controlled trial to achieve these aims.
Patients will receive either usual care + sipIT (intervention group) or usual care alone (control group). We will
evaluate 24-hour urine output, urine supersaturations, and fluid intake habit strength at baseline and 1, 3, and
12 months after intervention. If successful, this research will lead to a cost-effective intervention that leverages
consumer technology so it can be scaled for dissemination and implementation in clinical practice to reduce
the burden and cost of stones. It advances NIDDK goals of preventing noncancerous urologic diseases and
may be applied to support other dehydration-related health concerns (e.g., urinary tract infections, cognitive
performance, heat stress, post-surgical hospital readmissions).

Public health relevance
Project Narrative Fluid intake is a cornerstone of prevention for patients with kidney stones yet few patients adhere to fluid intake guidelines. Patient adherence can be supported by technology that monitors drinking behavior and delivers just-in-time reminders when patients have not had a drink recently. This project evaluates the efficacy of a sipIT, a digital tool involving a smartphone, smartwatch, and connected water bottle, for increasing fluid intake in patients with urolithiasis.